Administrative Core

ABSTRACT – Administrative Core
The Administrative Core provides comprehensive administrative and scientific management for all components
of the Duke Brain SPORE, including research Projects 1-3, three Shared Resource Cores, and both
Developmental Research and Career Enhancement Programs. Programmatic oversight will be provided by the
Administrative Core Co-Leads, as well as an Executive Committee consisting of Project and Core Leads and
Internal and External Advisory Boards. The functions of the Administrative Core will be carried out through the
following Specific Aims: 1) Provide administrative management and oversight; 2) Provide financial
management and ensure compliance with fiscal and research policies; 3) Provide oversight of all data
operations; 4) To promote integration within the SPORE and the Institution; 5) Maintain and support access to
an adequate cancer patient population; and 6) Provide scientific management and evaluate research
progress. Through these Aims, the Core ensures the full range of support required to provide administrative
management; promote integration, communication, and collaboration; ensure fiscal and regulatory compliance;
and oversee data operations, scientific rigor, and research progress. By serving these functions, the
Administrative Core allows SPORE investigators to focus on conducting and advancing the translational
science supported by the SPORE.

Public health relevance
PROJECT NARRATIVE – Administrative Core Primary brain tumors are the most frequent cause of cancer death in children and young adults. This Administrative Core provides infrastructure, leadership, coordination, integration, and oversight for the Duke SPORE in Brain Cancer to enable its translational research designed to improve outcomes for patients with primary brain tumors.